Genome sequencing of foodborne pathogens by the Pennsylvania GenomeTrakr group

Project summary/abstract (Overall)
The state of Pennsylvania and its associated GenomeTrakr network has consistently met all
obligations of the Food and Drug Administration’s program since joining in 2016. The
required personnel have worked seamlessly together, and effective standard operating
procedures have led to the uploading of over 2,000 quality genomes and associated
metadata to public databases. For this next funding cycle, we will continue this trajectory
while looking for opportunities to expand our impact within the Commonwealth,
particularly with the Pennsylvania Department of Agriculture. We will additionally expand
our international reach to further diversify collections submitted to the Pathogen Detection
database and to provide isolates for sequencing by other GenomeTrakr partners.

Public health relevance
Project Narrative (Overall) This project describes the integration of efforts within Pennsylvania to ensure yearly completion of the goals established by the United States Food and Drug Administration of populating databases with ever more genome sequences of foodborne pathogens. This will promote public health by advancing the use of whole genome sequencing as a tool for outbreak investigations.